Human Virome Characterization Center for the Oral-Gut-Brain Axis

Overall-Project Summary/Abstract
The NIH Human Microbiome Project has redefined our understanding of the human bacteriome, opening new
avenues of research in the biomedical and behavioral sciences and improving healthcare delivery. However, the
human virome remains largely unexplored. In response to this gap, the NIH Human Virome Program (HVP) offers
the opportunity to uncover the spectrum of “healthy” viromes across the lifespan, facilitating identification of
alterations associated with disease and further advancing biomedical research and healthcare delivery. Toward
this goal, we propose to establish this Human Virome Characterization Center (HVCC) for the Oral–Gut–Brain
Axis, a known functional unit with a central role in human health. Informed by our team’s long-standing expertise
studying these organs and their interconnected physiology, we will create an organizational hub for virome study,
leveraging multiple unique and diverse cohorts. Our goal is to identify and characterize the viruses comprising
the human virome across the oral–gut–brain axis, providing accurate estimates of its richness and complexity in
healthy cohorts across the life/healthspan. In support of this goal, we bring together investigators at several
institutions, including UCLA, Baylor College of Medicine, Mayo Clinic, Penn State, USC, UCSD, NIH/NIDCR,
with broad experience successfully guiding large NIH programs. We will establish five interacting Cores—
Administrative, Biospecimen Collection, Biospecimen Analysis, Data Analysis and Submission, and Ethical,
Legal, and Social Implications (ELSI)—that will work together to identify the viromes in numerous patient cohorts
diverse in age, race/ethnicity, each derived from the three target organs. Our Cores have interdisciplinary
expertise across key areas, including virome/microbiome sequencing, biomedical informatics/data science, and
patient recruitment/tissue banking, and will be tasked with handling multiple data types (virome/microbiome,
genomic, neuroimaging) to support the broad aims of our HVCC. The Biospecimen Collection Core will leverage
prospective cohorts and retrospective biospecimen banks at UCLA, Mayo Clinic, and NIH/NIDCR, as well as
several future cohort opportunities (All of US, Together for Change, AIIMS/India). Our Biospecimen Analysis Core
will use cutting-edge technologies to sequence the viromes in our biospecimens, and our Data Analysis and
Submission Core will analyze the data we collect using innovative bioinformatics, data science, and machine-
learning tools to uncover clinical, physiologic, and genetic interactions that shape the human virome. The ELSI
Core will provide policies and guidance and conduct original research to explore the ELSI of this work. The
Administrative Core will bridge the patient cohort teams with the supporting Cores to ensure seamless operation
and coordination with the broader HVP. Our Cores are designed to maximize the integration and sharing of ideas
through dynamic, contemporary communication methods, promoting refinement and dissemination of best
practices between our group and the wider scientific community. In doing so, this HVCC will provide a unified
framework to broadly advance our understanding of the oral–gut–brain virome toward improving human health.

Public health relevance
Project Narra+ve Our overarching objective is to ensure success of our human virome characterization center (HVCC) and fulfill the NIH’s vision for the human virome program (HVP). Our specific goal is to identify and characterize the viruses that comprise the human virome across the oral–gut–brain axis, providing accurate estimates of its richness and complexity in health across the lifespan in diverse cohorts. The oral-gut-brain axis is a recognized functional unit increasingly recognized as a central nexus for health and disease.